MAMMALIAN CELLULAR GENETICS AND CELL CULTURE

It is the purpose of this project to analyze and develop new and difficult systems for cell culture. We are now pursuing intensively a single cell system: culture of cells from the neonatal rat olfactory epithelium (OLFE). The projects involving thyroid gland reconstruction and thyroid cell genetics have been postponed. We hope to continue these timely experiments as soon as our principal collaborator, DR. F. S. Ambessi, can return to the laboratory. Meanwhile, our progress with the OLFE has been sufficiently exciting during the past year that it has merited our full attention. Using complex media and substrates we have succeeded in culturing several cell types from the OLFE. The mixed, mass cultures of these cells provide an appropriate conditioned medium that has permitted the isolation of 20 clonal cell strains from 3rd to 6th passage cultures. We have shown that several of our cloned cell lines have sensitive (submicromolar) and selective (different response patterns in each line) odorant- dependent second messenger responses (both cAMP and CaH). This fact coupled with our demonstration that these same cell strains are positive for neuron-specific enolase now establish that we have right cell type in culture. We have continued the hybridoma screen using OLFE as antigen and fluorescent anti-mouse IgG staining of frozen sections of OLFE for selection. Development of this system would make available the first mammalian neuroblast to neuron cell culture system and provide a means to study the growth and differntiation dichotomy common to all blast cell systems. It is hoped that basic issues in olfactory sensory physiology can be explored with this system.